Elucidating the Biology of Cardiovascular Risk in Hemodialysis Patients Using Proteomics

PROJECT SUMMARY
The 500,000 patients in the United States with end-stage renal disease (ESRD) on hemodialysis (HD) suffer
extraordinarily high rates of mortality at ~18% per year, with 50% of these deaths attributed to cardiovascular
disease (CVD): namely, atherosclerotic CVD, heart failure, and sudden cardiac death. Effective approaches for
prevention, treatment and risk stratification in the HD population are lacking. Medical therapies that are
effective in patients without ESRD, such as statins, are not beneficial for patients with ESRD when tested in
randomized clinical trials. Ironically, traditional CVD risk factors, such as hypercholesterolemia, obesity, and
hypertension, have `reverse' associations with CVD outcomes among these patients as compared to the
general population. Major obstacles to progress in these areas that are addressed in our proposal include: 1)
poor understanding of the disturbed biology in patients on HD that leads to poor CVD outcomes; and 2) failure
to consider CVD in the HD population as a complex, potentially heterogeneous entity that calls for a
personalized approach to CVD risk stratification using CVD models that are individualized and whose risk
factors are modifiable. Circulating protein levels can serve as modifiable biomarkers for CVD risk, guide
therapy and elucidate causal biological pathways and mechanisms. We plan to take advantage of an advanced
modified aptamer assay (SOMAscan) that measures ~ 5000 proteins in just 175µl of plasma with high
sensitivity and specificity. To date, no studies have utilized large-scale proteomics to understand outcomes and
biological mechanisms in patients with ESRD on HD. In Aim 1, we propose to study proteins associated with
clinical CVD outcomes in 649 participants of the Chronic Renal Insufficiency Cohort (CRIC) who have had one
or more study visits after initiation of HD, and validate our findings in 408 participants in the Predictors of
Arrhythmic and Cardiovascular Risk in ESRD study. In Aim 2, we will investigate changes in proteins that
associate with progression or regression of left ventricular mass in the Frequent Hemodialysis Network, and
validate our findings in CRIC. Proteomics will be measured at two time-points 1-2 years apart in 2/3 of the
1324 participants so that we may study single time-point proteins as well as protein trajectories. We will employ
innovative methods, including stratified Cox analyses that support differing baseline hazards for participants
with and without CVD, and time-dependent covariates for risk models, to accommodate intervening events in
our analysis of protein changes. Agnostic and targeted pathway analyses will elucidate biological networks
among protein predictors. In carrying out these Aims we will create accurate, personalized and mutable risk
models for CVD events in HD patients. We will identify heretofore-unknown proteins and biological pathways
associated with CVD; some of these may eventually become targets for interventional strategies for ESRD
patients on HD, who are in great need of new therapies to improve their poor outcomes.

Public health relevance
Project Narrative Patients with end-stage renal disease on hemodialysis have frequent hospitalizations and poor survival, due in large part to cardiovascular disease: namely, atherosclerotic disease, heart failure, and sudden cardiac death. We currently lack models to effectively risk stratify these patients, and we have a poor understanding of the biology underlying their high rates of cardiovascular morbidity and mortality. We intend to apply a novel test, capable of measuring ~5000 proteins in a tiny blood sample, to over 1000 patients with end-stage renal disease on hemodialysis; we aim to discover proteins that would help us pinpoint cardiovascular risk and understand the disturbances in the biology in these patients, with the goal to carry forward novel proteins as potential targets of new treatments for this vulnerable population.